Targeting TEMs in Preclinical Tumor Models

The growth of new vessels, or angiogenesis, is essential for tumor growth. Targeting the endothelial cells that line vessels is a promising anticancer strategy. We have recently identified several cell surface tumor endothelial markers (TEMs) that are conserved in both mouse and humans and that represent potentially useful targets for anticancer therapy. To determine whether these TEMs are in fact useful targets, we will begin translational studies using transplantable tumor models in mice. To target cell surface TEMs, we will utilize a panel of recently developed antibodies that we have found can recognize native TEM proteins on both mouse and human tumor vessels. We will begin our studies by attempting to target TEM8, but later on may also attempt to target other cell surface TEMs such as TEM1, TEM5 or TEM7. Initial studies will involve labeling the antibodies with various markers that will allow us to monitor biodistribution following injection into tumor bearing mice. Subsequently, antibodies with the best sensitivity and specificity will be conjugated to toxins and tested for their tumoricidal properties in preclinical mouse models.